Zebrafish Screens to Identify Agents which Reverse the Effects of Synthetic Opioids

Project Summary/Abstract
Drug-use and addiction are complex social and medical issues and many strategies are being employed
to decrease the detrimental effects of opioid addiction. The United States is in the midst of an opioid epidemic.
The first-line treatment for opioid overdose is the opioid antagonist, naloxone, which competes for binding to
the orthosteric site of µ-opioid receptors (MOR). Unfortunately, naloxone exhibits decreased effectiveness in
cases of overdose involving potent synthetic opioids, often requiring repeated administration. This study seeks
to identify novel counter-measures for synthetic opioids, with an emphasis on fentanyl.
This project will identify novel agents which reverse the effects of fentanyl. We will utilize larval zebrafish
as an in vivo high-throughput competitive environment to measure the ability of substances to counter-act the
effects of synthetic opioids. The zebrafish paradigm also models drug uptake and biodistribution, which are
recognized as being important contributors to the clinical interactions between opioids and naloxone.
Commercially available screening libraries will be filtered to define a library of thousands of compounds
with physiochemical properties which forecast CNS drug-likeness. In Aim 1, this library will be procured and
tested for ability to reverse the effects of fentanyl in a novel photomotor response (PMR) assay we have
developed. Preliminary data within the application provides high confidence that we will be able to use this
PMR assay to successfully identify novel chemical classes which work via conventional competitive orthosteric
inhibition of the MOR to reverse the effects of synthetic opioids. This is a likely outcome which is valuable in
its own right and relatively low risk. The high-risk/high-reward prospect of this work is the potential identification
of novel chemical classes which work via non-MOR mechanisms to reverse overdose from synthetic opioids.
This is a unique advantage of the PMR phenotypic screen, which provides the opportunity to identify agents
working via non-MOR mechanism- an outcome which target-based approaches cannot provide. Hit
compounds capable of reversing the effects of fentanyl in an equivalent, or improved, fashion relative to
naloxone will be studied in a follow-up confirmatory assay (Aim 2) focusing on ability to rescue fentanyl induced
depression of cardiovascular function in zebrafish.
Upon completion, this screening campaign will deliver novel small molecules capable of reversing the
effects of synthetic opioids. Such molecules are anticipated to work as: 1) novel MOR allosteric modulators,
2) novel MOR orthosteric antagonists, and/or 3) novel agents acting via a non-MOR mechanism. Successful
compounds will have favorable physiochemical properties as potential CNS agents and have demonstrated
in vivo efficacy, which presumably dictates adequate CNS exposure and BBB penetration. As such, the ‘hits’
delivered from this project will serve as excellent starting points for future hit-to-lead optimization campaigns.

Public health relevance
Project Narrative Several approaches are being pursued to address the opioid epidemic, including the development of new pain management strategies and limiting illicit transport/sale of narcotics. Nonetheless, synthetic opioids will likely continue to be abused substances for the foreseeable future. This work focuses on the identification of novel counter-measures capable of reversing overdose from synthetic opioids.